Examining Health Disparities in the use of Hematopoietic Cell Transplants for HIV-related Lymphoma

Project Summary/Abstract
People living with HIV (PLWH) are at increased risk of developing HIV-related lymphoma, are less likely to
receive cancer treatments such as chemotherapy and radiotherapy, and the likelihood of receiving a curative
treatment such as hematopoietic cell transplant (HCT) for HIV-related lymphoma is unknown. There are no
definitive guidelines for HCT use in HIV-related lymphoma, despite studies demonstrating equivalent overall
survival between those with and without HIV. Current evidence is limited by small samples or single-center
studies conducted with highly specialized infectious disease teams. Clinical challenges unique to HIV include
added risks for infections and hospitalizations, and drug-drug interactions between antiretrovirals and
chemotherapy, contributing to the lack of HCT adoption in HIV-related lymphoma. Inequities in HCT utilization
in HIV-related lymphoma are influenced by social determinants of health. Patients who are Black/African
American, do not have private insurance, and have low socioeconomic status are less likely to receive HCT in
general, but these barriers to HCT in HIV-related lymphoma have never been studied. This proposal will
characterize the social determinants of health that influence HCT utilization in patients with HIV-related
lymphoma, and elucidate if supportive measures are needed to address differences in care outcomes based
on HIV status. Our central hypothesis is that in HIV-related lymphoma patients, certain social determinants of
health are associated with less HCT utilization, and that PLWH have distinct treatment burden and hospital
use. We will test our hypothesis via the following Specific Aims: 1) Measure the associations between
sociodemographic and clinical factors on HCT utilization in patients with HIV-related lymphoma, and 2) Test for
differences in treatment burden, hospital use, and survival outcomes between lymphoma HCT recipients with
and without HIV. Our research team at UC Davis linked an innovative dataset using the Center for International
Blood and Marrow Transplant Research (CIBMTR), California Cancer Registry, and California Patient
Discharge Data that will be used in cohort and matched case-control designs in this F31 proposal. By
completing the training objectives in this F31, the applicant will gain the skills necessary to become an
independent nurse scientist and Principal Investigator, while characterizing inequities in HCT utilization and
disparities in care outcomes influenced by social determinants of health. Specifically, through a mentoring
team spanning UC Davis, UC San Francisco, and Stanford University the F31 applicant will 1) Acquire skills in
epidemiologic approaches (population health), secondary analysis, and advanced biostatistics, 2) Gain HIV
clinical management expertise, 3) Advance knowledge in health equity, health disparities, and social
determinants of health, and 4) Leadership and professional development to become a principal investigator.

Public health relevance
PROJECT NARRATIVE As the U.S HIV population ages the proportion of those diagnosed with cancer (such as HIV-related lymphomas) will continue to rise, emphasizing an urgent need for equitable access to curative lymphoma treatments such as hematopoietic cell transplants (HCT). This project will characterize the inequitable utilization of HCTs based on social determinants of health among California patients with HIV-related lymphomas, and elucidate differences in care outcomes based on HIV status and transplant type. Through the use of an innovative linked cancer registry dataset, the findings from this project will expand the knowledge base on inequitable HCT utilization and the related social determinants of health to support interventions that will close the gap in health disparities within this vulnerable population.